Project III: Innate immunity, Vascular Dysfunction and HTN during Pregnancy

PROJECT SUMMARY
Women with hypertensive pregnancies have increased immune activation (CD4+ T cell activation, AT1-AA
producing B cells, inflammatory cytokines) and increased risk of cardiovascular disease (CVD) and cerebral
vascular dysfunction (CBD) later in life. Antigen presenting cells (APCs), including macrophages (Mɸs), modulate
innate and adaptive immune responses to the fetus during pregnancy. Recent studies indicate that secretion of
cytokines and expression of co-stimulatory proteins from pro-inflammatory (M1) Mɸs mediate a pro-inflammatory
immune response in other diseases. Placental ischemia induces increased M1 Mɸs during pregnancy. However,
1) it is not known if M1 Mɸs play a role in causing vascular dysfunction and hypertension (HTN) during pregnancy
by inducing oxidative stress, activating B cells to produce agonistic autoantibodies to the angiotensin type 1
receptor (AT1-AA) or polarizing CD4+ T helper (TH) cells into pro-inflammatory effector cells. Furthermore, 2) it
has not been determined if M1s persist postpartum (PP) to promote chronic vascular dysfunction leading to
increased CVD risk later in life. We hypothesize that placental ischemia induces increased placental M1 Mɸs,
which secrete pro-inflammatory cytokines, polarize pro-inflammatory effector CD4+ TH cells and stimulate B cell-
mediated AT1-AA production to cause oxidative stress, endothelial activation, renal injury and vascular
dysfunction, leading to HTN and fetal growth restriction (FGR) during pregnancy. These M1s persist PP,
mediating a decline in systemic and cerebral vascular function causing HTN and cognitive impairment long-term
in the mother. To test this hypothesis, we will use a well-established clinically relevant model of PE; Reduced
Uterine Perfusion Pressure (RUPP) rat model. We will also employ our novel model utilizing human macrophage
adoptive transfer into immunocompromised pregnant rats. We will leverage these models to identity novel
mediators of PE pathophysiology and test innovative therapeutic strategies to mitigate progression of PE and
the long-term effects on cardiovascular and cerebral vascular health. We will employ physiological and
pharmacological approaches complemented with molecular, biochemical, and in vivo techniques to address
vertically integrated specific aims. The proposed studies will provide new and important information regarding
the pathophysiological mechanisms linking placental ischemia with maternal HTN and FGR during PE, and with
long-term CVD risk in the mother after a PE pregnancy. More importantly this study will identify novel therapeutic
targets for the treatment of PE.

Public health relevance
Narrative Despite its position as a leading cause of maternal death and major contributor to maternal and perinatal morbidity, there is no effective drug treatment to prevent preeclampsia (PE). At present, the only effective treatment for PE is early delivery of the baby and placenta. Based on recent studies and on preliminary data presented in this application, we propose that M1 macrophages are a novel therapeutic target for the treatment of PE.